Molecular characterization of biliverdin IXbeta reductase

Project Summary/Abstract
Research proposed in this grant application builds on extensive genetic, biochemical and animal studies
designed to further characterize and validate biliverdin IXβ reductase (BLVRB) as a novel cellular target
regulating human platelet production in situations of stress hematopoiesis, with concomitant effects on
erythroid development and repopulation. Although heme degradation is largely studied as a processing
pathway designed to clear pro-oxidant (free) heme generated during cellular senescence (or metabolism),
heme catabolic enzymes are also known to maintain function(s) in cellular signaling and cytoprotection, and
tetrapyrrole byproducts biliverdin (BV) and bilirubin (BR) function in redox reactions as potent buffer(s) against
oxidant stress. We now challenge existing dogma, hypothesizing that redox-regulated activity involving heme
catabolism functions in a unique metabolic pathway controlling hematopoietic lineage fate with divergent
effects on erythroid/megakaryocyte balance. Research goals are accomplished through two synergistic
specific aims, designed to (1) delineate cellular mechanisms of BLVRB-regulated Mk/Erythroid redox coupling
and cytoprotection in vitro, and (2) define and expand upon mechanisms of lineage-restricted speciation and
cytoprotection in vivo, collectively designed to dissect Blvrb-regulated perturbed pathways controlling E/Meg
lineage speciation from MEPs during stress hematopoiesis. Basic science implications are broadly relevant to
(1) metabolic and bioenergetic consequences of hematopoiesis, (2) heme-regulated redox chemistry, and (3)
novel cellular target validation. Clinical/translational implications are designed to enhance our understanding
of mechanisms of disease pertaining to stem cell metabolism, aging, anemia and platelet production. Unique
reagents and cell lines generated and characterized include (1) murine models of Blvrb- and Blvra-deficiency,
(2) iPSC models with targeted BLVRB knock-outs, (3) biliverdin IXβ (and IXγ, IXδ) isomer detection and
production methodologies. All proposed studies are formulated on pre-existing studies in subject cohorts, and
proposed experiments are predicated on reagents and expertise currently available or in advanced
development among the research team.

Public health relevance
Public Health Relevance/Project Narrative Understanding how blood cells are produced is fundamentally important to human health. We applied genetic studies in humans to identify a new cellular enzyme associated with increased platelet counts, and now propose to further characterize how metabolic function(s) involving the enzyme and its cellular pathway components affect human platelet production and erythrocyte development. This direction of research highlights its importance for blood cell development, most prominent in situations of aging or stress. During the grant period, we propose to complete more detailed biochemical and genetic studies to further study its mechanism of action. Animal models will be used for sophisticated mechanistic studies; comprehensive studies in mice will also provide novel insights into the mechanism(s) of stress hematopoiesis, relevant to human inflammatory conditions and/or patients receiving chemotherapy. Initial goals of characterizing novel chemical inhibitors based on our sophisticated structural models, are predicted to provide important pre-clinical data supporting more future drug development aimed at increasing human platelet counts. All the work proposed in this application builds on studies in humans with significant impact on translational studies designed to increase our understanding of metabolic regulation of blood cell development.